Shifting Rehabilitation Paradigms in Skilled Nursing Facilities

? DESCRIPTION (provided by applicant): Project Summary Abstract There is growing recognition that acute hospitalization contributes to marked functional decline in older Veteran populations. Nearly 20% of all hospitalized older adults are discharged to a skilled nursing facility (SNF) to address these functional deficits. Unfortunately, rehabilitation in SNFs does not adequately restore physical function, which directly contributes to poor community discharge rates. Strikingly, only 27.8% of all patients admitted to SNFs are discharged to a community setting, which suggests a paradigm shift is required to optimize rehabilitation within SNFs. Currently, usual care rehabilitation in SNFs consists of low-intensity rehabilitation interventions, which are physiologically inadequate to induce meaningful changes in skeletal muscle strength and physical function. Therefore, we propose a novel IntenSive Therapeutic Rehabilitation for Older skilled NursinG HomE Residents (I-STRONGER) program, which integrates principles of physiologic tissue overload into combined strengthening and functional interventions for greater gains in physical function. The overall goals of this investigation are to 1) demonstrate feasibility of I-STRONGER in SNF settings and 2) determine the effectiveness of I-STRONGER in improving physical function. A comparison of usual care (UC) with I-STRONGER will occur using a staged, 2 group design (independent cohorts), with a single SNF serving as its own control. The first cohort of SNF patients will participate in UC (Stage 1) and after therapist training on I-STRONGER is completed, a second cohort of patients entering the same facility will participate in I-STRONGER (Stage 2). The feasibility of I-STRONGER will be evaluated by patient acceptability and therapist compliance measures. Functional outcomes will be evaluated at admission and discharge including: Short Physical Performance Battery, Timed-Up-and- Go, gait speed and Barthel Index.

Public health relevance
PUBLIC HEALTH RELEVANCE PROJECT NARRATIVE This study focuses on two prevalent and understudied problems for medically-complex, older Veterans: inadequate recovery of physical function and low rates of community discharge after a skilled nursing facility (SNF) stay. This investigation has high potential to change current rehabilitation paradigms by addressing the preponderance of low-intensity, non-specific rehabilitation interventions, which contribute to long-term deficits in physical function and risk for institutionalization. We propose to change rehabilitation practice b applying principles of high-intensity to strengthening and functional activities to improve physica function and community discharge rates for Veterans receiving SNF care.